Enhancing research grant management capability and administrative infrastructure

DESCRIPTION (provided by applicant): The establishment of the Research and Sponsored Projects Office (RSPO) in 2003 as a joint venture between the Moi University, School of Medicine (MUSOM), the Moi Teaching and Referral Hospital (MTRH) has resulted in improved financial and administrative management of funds awarded to the two institutions. RSPO autonomously administers research and service grants awarded to MUSOM/MTRH and aims to use this proposal to enhance the research grant management capability and administrative infrastructure in MUSOM/MTRH. Specific objectives to be achieved include training of key RSPO personnel on National Institutes of Health policies and procedures, enhancing the existing infrastructure in RSPO, empowering RSPO staff to train faculty in grants application and management, extending RSPO's expertise to other Schools within Moi University as well as other academic and scientific institutions in East Africa and establishing a Grants Advisory Board to provide strategic guidance to RSPO. These will be attained through participation in the long distance learning and residency program organized under this award; purchase of office supplies and equipment and installation of financial software to upgrade the existing infrastructure to enable better tracking project funds; development of a grants management curriculum that will be used to train faculty and students on grantsmanship through workshops and an online grants management course. RSPO will also develop an institutional website on grants application and management that will be linked to the MUSOM and MTRH websites. It is also proposed that RSPO will extend its expertise to other universities currently collaborating with MUSOM/MTRH in research through teleconferencing, training and site visits and offering mentorship on grants management. The implementation of each of these objectives will be monitored by a Grants Advisory Board so as to ensure that the planned activities are in line with the overall strategic plan of MUSOM/MTRH. The attainment of these aims will not only provide the much need financial and administrative support to researches in health and other disciplines in the region but also help RSPO advance its goal of being a centre of excellence in grants management in the East African region.

Public health relevance
PUBLIC HEALTH RELEVANCE: The participation of the Research and Sponsored Projects Office (RSPO) in this award will provide the much needed financial and administrative support to researchers in public health, clinical practices and other disciplines at Moi University School of Medicine and Moi Teaching and Referral Hospital by imparting them with the skills to successfully apply for funding for biomedical and behavioral research. This award will also enhance the capacity of RSPO to manage the increasing number and complexity of grants and contract as per NIH and other US federal agency requirements. PROJECT NARRATIVE The participation of the Research and Sponsored Projects Office (RSPO) in this award will provide the much needed financial and administrative support to researchers in public health, clinical practices and other disciplines at Moi University School of Medicine and Moi Teaching and Referral Hospital by imparting them with the skills to successfully apply for funding for biomedical and behavioral research. This award will also enhance the capacity of RSPO to manage the increasing number and complexity of grants and contract as per NIH and other US federal agency requirements. __SpecificAimsTextDelimiter__ SPECIFIC AIMS There has been exponential growth in research management at the Moi University School of Medicine (MUSOM) and Moi Teaching and Referral Hospital (MTRH) since 2003. The longstanding partnership of these two institutions with Indiana University School of Medicine (IUSM) and other universities in the USA has contributed greatly to the development of research management capability through capacity building and continuous training and mentorship of the staff at the Research and Sponsored Projects Office (RSPO). This has made RSPO capable of addressing the administrative and financial aspects of grants awarded to MUSOM/MTRH as required by external funding agencies. Through this application and the training that the nominees will receive through their participation in the NIH residency and distance learning program, the nominees will enhance the existing infrastructure to improve the solicitation and administration of grants, train faculty in grants application and management procedures, and provide mentorship to other Schools within Moi University and other academic and scientific institutions in East Africa. In order to accomplish this objective, we propose to implement the following specific aims: 1. Gain expertise in NIH policies and procedures governing grants applications and administration to be able to facilitate training of investigators and other key RSPO staff in the requisite policies and procedures to submit grant proposals electronically through www.grants.gov and administer grants from US government funding agencies in a manner that is efficient, effective, transparent, and accountable. 2. Strengthen RSPO's budgetary and regulatory capabilities and oversight by upgrading its computer network and grant management software programs, gaining expertise in the use of these tools, training and supporting internal and external staff in their use, and enhancing procedural communication with investigators and their support staff. 3. Strengthen the link between the RSPO, the Institutional Research and Ethics Committee (IREC) of MUSOM/MTRH and their partner US universities to assure a coordinated, timely review and submission of grant proposals through the development of a website to include developed institutional research policies and procedures, requisite forms and instructions and funding agency guidelines. 4. Develop a grants application and management curriculum and train faculty, staff and students on grantsmanship. 5. Strengthen the research grants application and management capabilities of other schools and campuses in Moi University and scientific institutions in East Africa by engaging, training, mentoring, and establishing communication among their research administrators. 6. Establish a Grants Advisory Board (GAB) that will review and monitor RSPO's on-going research infrastructure development activities and evaluate the performance of RSPO in its quest to improve and expand the MUSOM/MTRH research enterprise. The attainment of these aims will help RSPO advance its goal of being a center of excellence in grants management in the East African region.